EFFECT OF ESTROGEN GLUCOSE/LIPID METABOLISM IN POSTMENOPAUSAL DIABETIC WOMEN

Evaluate glucose and insulin mechanics in diabetic women treated with ERT using the frequently sampled intravenous glucose tolerance test (FSIVGTT).